Core B: Technology, Assessment, Data, and Analysis Core

PROJECT SUMMARY / ABSTRACT
The Technology, Assessment, Data, and Analysis (TADA) Core will support the COBRE for Stress,
Trauma, and Resilience (STAR) in leveraging novel technological, methodological, design and analytical
approaches to enrich research projects and public health impact. The TADA Core will provide support for an
array of innovative and state-of-the-field methods for current and future Project Leaders, the STAR faculty
recruit, and Pilot Project Investigators within the STAR COBRE. Specifically, the TADA Core will offer unique
expertise in leveraging technology for observational, laboratory, and intervention studies critical for (1)
obtaining ecologically-valid data on stress exposures and behavioral and physiological responses with high
temporal resolution, (2) novel approaches to digital phenotyping, and (3) electronically-delivered adaptive
interventions. Technological innovations are rapidly progressing, and the TADA Core will provide a centralized
resource for training and exchange of expertise about innovative and emerging technological approaches.
The TADA Core will house unique Core equipment (e.g., eye tracking machine/computer) and software
(e.g., Ilumivu) that will expand over time to meet the needs of current PLs, PPs, new PLs, and the STAR
faculty recruit. The TADA Core will also provide support for additional assessments including mixed
quantitative and qualitative methods, data management and electronic data capture, and sophisticated
statistical analysis for longitudinal, complex data. Finally, the TADA Core will create a unique repository of
data from STAR COBRE projects that will be available for secondary publications and grant applications and
will serve as a resource for future Pilot Investigators, Project Leaders, and the STAR faculty recruit. The TADA
Core will also offer biospecimen tracking, storage, and processing services to meet the needs of current and
future projects. The aims of the TADA Core are to: (1) Provide expertise and services to support study design,
technology implementation, assessment, and statistical analyses for COBRE-affiliated projects, (2) Serve as a
centralized resource for research training and the exchange of methodological, technology design/
implementation, and analytic approaches related to the study of stress, trauma, and resilience, and (3) Provide
expertise and services to support data management and create a repository of data that can serve as a
resource for STAR COBRE investigators. Our long-term goal is to provide a sustainable resource to help
investigators apply innovative and integrated methodological approaches, with matched analytic strategies to
the study of stress, trauma, and resilience.